Lumbricus terrestris erythrocruorin (LtEc) as a red blood cell substitute in normothermic ex vivo kidney perfusion

PROJECT SUMMARY
The ability to maintain the viability and function of organs outside the body (ex vivo) at body temperature
(normothermia) is an emerging field of innovation. Normothermic ex vivo perfusion systems have been
developed to maintain hearts, lungs, and livers in this fashion for up to several days and have been a valuable
tool in transplantation medicine to extend the longevity of donor organs. The potential for these technologies to
be utilized in other ways is now also being recognized. Normothermic ex vivo kidney perfusion (NEVKP), in
comparison, has been more challenging to develop. The kidney is highly susceptible to damage from the
products of red blood cell (RBC) degradation that are generated by machine perfusion. Because of this, existing
NEVKP systems cannot reliably sustain the viability of kidneys beyond 24 hours. The goal of this project is to
investigate whether this challenge can be overcome using a promising RBC alternative: the naturally
acellular hemoglobin (erythrocruorin) of the earthworm Lumbricus terrestris. We aim to use this novel oxygen
carrier to extend the duration of NEVKP, making it a more viable tool for kidney disease research.
L. terrestris erythrocruorin (LtEc) has many properties suggesting it would be an ideal oxygen carrier for NEVKP.
Having evolved to transport oxygen in an extracellular environment, LtEc is molecularly stable in a wide range
of temperatures, has a low oxidation rate, and does not scavenge nitrous oxide (NO), an important vasodilator.
Its size (30 nm) is favorable for perfusing the kidney as it would likely not get lost to glomerular filtration (6-8 nm
cutoff) but remain able to perfuse vasoconstricted capillaries that are inaccessible to RBCs (8 µm). Together
with preliminary results from our lab demonstrating that LtEc can sustain respiration in NEVKP, these properties
strongly justify investigating the utility of LtEc in NEVKP.
In this proposal, we will first evaluate LtEc by testing different LtEc concentrations in an NEVKP system against
autologous porcine RBCs as a control. We will investigate the ability of LtEc to support kidney function and
viability while monitoring adverse effects including oxidative stress, inflammation, and kidney injury. These
experiments will help determine the concentration that best supports respiration and minimizes toxicity during
NEVKP. LtEc will also be evaluated against other HBOCs to determine whether the advantageous molecular
properties of LtEc confer an empirical benefit in NEVKP. We will then attempt to maintain NEVKP for up to 7
days using an LtEc-based perfusate.
Optimizing the use of LtEc for NEVKP of porcine kidneys could result in two major breakthroughs: 1) the
development of long-term NEVKP, a tool that would enable many avenues for novel discovery in kidney disease;
and 2) the validation of LtEc as an effective and sustainable oxygen carrier in a mammalian organ, the impact of
which could be relevant to numerous fields across medicine.

Public health relevance
PROJECT NARRATIVE Our goal is to develop a long-term normothermic ex vivo kidney perfusion tool by using the extracellular hemoglobin (erythrocruorin) of the earthworm Lumbricus terrestris as an alternative to red blood cells. We will aim first to optimize the concentration of erythrocruorin for ex vivo kidney perfusion with respect to its efficacy and side effect profile compared to red blood cells and other oxygen carriers. We will then enhance the durability of erythrocruorin and extend the duration of normothermic ex vivo kidney perfusion for up to 7 days.